Rapid Diagnostic for Human Cytomegalovirus (HCMV) Serological Status

This proposal aims to develop a point-of-care diagnostic to detect the presence of antibodies against human cytomegalovirus (HCMV).